Development of Oculomotor Circuits in Nystagmus

Infantile nystagmus syndrome is an involuntary oscillatory movement of the eyes that begins in infancy and
persists throughout life. It is visually and socially debilitating. The underlying pathophysiology is poorly
understood, and no effective treatments exist. More than half of infantile nystagmus patients have an associated
retinal or optic nerve disorder. Nystagmus is thus thought to develop secondary to poor vision, suggesting that
proper development of the oculomotor system is dependent on visual input, particularly in the first two months
of life. The long-term goal of this research is to understand the pathophysiologic mechanisms in nystagmus
and identify potential new therapeutic targets. Extraocular muscles (EOMs) from patients with infantile
nystagmus display a number of abnormalities, including decreased innervation, small neuromuscular junctions,
and an increased proportion of slow myofibers. We have recently shown that these changes are also present
in a mouse model of nystagmus—albino mice—and that the first changes are present as early as P10, before
eye opening. The human samples also show central nucleation of muscle fibers and an increase in expression
of the immature form of acetylcholine receptor on the fast myofibers. These changes suggest that there is
continuous remodeling of the EOM innervation in nystagmus. Different EOM myofiber types are innervated by
different subtypes of oculomotor neurons (OMNs), which in turn receive different premotor inputs. The “fast”
and “slow” OMNs, which innervate fast and slow myofibers, respectively, have different roles in different types
of eye movements. EOMs, OMNs, and premotor inputs are all dependent on each other for survival. This leads
to the hypothesis that nystagmus results from improper development of the oculomotor circuitry. This proposal
aims to test this hypothesis in a mouse model of infantile nystagmus syndrome by (1) determining whether
OMN survival and subtype distribution are altered and how the developmental timing of any changes relate to
changes in EOM innervation and nystagmus onset and (2) determining whether the premotor synaptic inputs to
the OMNs develop abnormally in mice with nystagmus. Albino mice, which display spontaneous nystagmus,
will be assessed for changes in EOM innervation and myofiber subtypes and corresponding differences in
OMN survival and subtype distribution. Age of onset of nystagmus will be determined. Viral transsynaptic
tracing will delineate the first-order synaptic connections onto the ocular motor nuclei. In all experiments, albino
mice will be compared to wild-type littermates, obtained from heterozygous matings, to control for genetic
background. Multiple developmental timepoints will be assessed to determine the point in development when
changes associated with nystagmus occur; whether changes in the EOMs, OMNs, or premotor inputs occur
first; and which changes precede nystagmus onset. This research will provide fundamental knowledge into the
mechanisms of infantile nystagmus. Understanding where and when the abnormalities in infantile nystagmus
first arise is the first step in identifying potential therapeutic targets or preventative interventions.

Public health relevance
Infantile nystagmus syndrome, an involuntary oscillation of the eyes that develops in the first six months of life, is both visually and socially debilitating, but how and why it develops is poorly understood. This project aims to understand how and when development of the neural circuitry responsible for eye movements is altered in a mouse model of nystagmus. This work will both provide fundamental knowledge about neurodevelopment and identify new therapeutic targets for treatment or prevention of infantile nystagmus.